Prohibiting Cell Death in Human Keratocytes: New Insights for Non-surgical Keratoconus Treatment

Project Summary/Abstract
Keratoconus (KC) is a progressing cornea disorder that causes one in every 500 to 2000 Americans to see
distorted images with a cone-shaped cornea. 10-20% of KC patients will ultimately require cornea transplant
surgeries. Keratocyte apoptosis and collagen degeneration in the cornea lead to stromal thinning, which
further induces KC. Up to today, there is no therapy targeted to keratocyte apoptosis. This proposal aims to
search for non-surgical treatments for KC cases by inhibiting extrinsic apoptotic in keratocytes under
extracellular stress. The human tumor necrosis factor – alpha (TNF-α), a cytokine released in the
inflammation response, will bind its cell surface receptors with the assistance of heparan sulfate (HS)
proteoglycan (PG). Upon binding with TNF-α, the TNF receptors will start protein recruitment intracellularly,
which leads to the self-cleavage of procaspase-8 dimer and the activation of caspase-8 (CASP8). CASP8 will
cleave the executive caspases downstream and initiate the cascade of extrinsic apoptosis.
This proposal aims to find small molecule compounds that inhibit activated CASP8 (AIM 1) and HS
compounds that inhibit interactions between TNF-α and TNF receptors (AIM 3). To accomplish CASP8
inhibition, I propose unbiased proteomics approaches facilitated by sample multiplexing mass spectrometry
and antibody-based assays for markers of apoptosis. To find HS compounds that can interrupt TNF-α and
TNF receptors interaction, I will utilize glycan microarray technology to screen over 90 HS compounds with
different sulfation patterns and chain lengths. I will use 2D-solution nuclear magnetic resonance (NMR)
spectroscopy to obtain kinetics of associated protein-ligand interactions (AIM 1) and validate keratoconic
effects of the apoptotic inhibitions in 3D-KC cell models (AIM 2&3).
This proposal will benefit from my analytical instrumentation skills, including mass spectrometry and
solution NMR, and my knowledge about characterizing biomacromolecules, including proteins (proteomics)
and glycosaminoglycans (glycomics). I will obtain further training in KC biology and pathology and advanced
drug screening pipeline development. During the mentored K99 phase, I will 1) develop an advanced pipeline
of drug discovery targeting keratoconic stromal cell apoptosis, 2) strengthen my knowledge in KC biology, 3)
build connections between proteomics and glycomics around KC research, and 4) enhance my professional
skills needed to be a successful independent investigator. The project will be conducted under the advisory of
my mentor Dr. Steven Gygi and my advisory committee: Dr. Dimitrios Karamichos, Dr. Yutao Liu, Dr. Jian Liu,
and Lianchun Wang. Harvard Medical School Cell Biology Department will also provide excellent opportunities
for my training. The proposed research strategy, combined with the career development training, will guide me
to become an independent investigator in the field of Keratoconus biology.

Public health relevance
Project Narrative Stromal cell apoptosis plays essential roles in keratoconus pathology, which can be inhibited through covalent and non-covalent ligands. This project established an advanced drug screening pipeline facilitated by high- throughput technologies including mass spectrometry, in-cell ELISA, and glycan microarrays. The proposed analytical platform has great potential to discover novel non-surgical keratoconus therapies targeting the extrinsic apoptosis pathway and can be also utilized in other corneal dystrophies.